San Diego Center for AIDS Research (SD CFAR)

Overall Project Summary/Abstract
The mission of the San Diego Center for AIDS Research (SD CFAR) is to drive HIV discoveries and foster
cutting-edge research by San Diego investigators to improve the lives of people with HIV and to stop new
infections, both locally and globally. Our Center’s research priorities are aligned with the NIH Office of AIDS
Research priorities and include preventing new infections, optimizing HIV care, and developing a cure, while
promoting health equity for people with and at risk for HIV.
The specific aims of the SD CFAR are to:
1. Accelerate the pace of discovery by providing the foundation for productive collaborations across fields,
investigators, member institutions, and the HIV community.
2. Capitalize on our community engagement and international partnerships to develop sustainable research
programs that can inform policy, practice, and implementation.
3. Provide Training, Inspiration, Mentoring, and Expert guidance (TIME) to local and international investigators
across career stages.
4. Provide scientific and administrative leadership to CFAR member institutions, investigators, and across our
region.
Structure: The SD CFAR is multi-institutional, with members at La Jolla Institute of Allergy and Immunology (LJI),
San Diego State University (SDSU), Scripps Research (SR), and University of California San Diego (UCSD).
The Center is co-directed by members of our Operations Team including Drs. Davey Smith (contact PI), Douglas
Richman, Sonia Jain, Dennis Burton, and Jamila Stockman (Leadership Trainee). Our CFAR is comprised of
eight Cores and one Scientific Working Group. We continue to be guided by our Advisory Committees, as well
as our Co-Directors, Core Directors, Scientific Working Groups, and our membership.
Progress: Since our renewal in 2017, SD CFAR efforts have yielded a productive and growing group of
investigators whose research work extends from cellular restriction factors that impede HIV replication and
transmission to behavioral approaches to improve prevention and treatment. Our funded research base
remained at Tier 3 status and steadily increased by $11.9M between FY18 - 21. Further, there have been 870
CFAR-supported publications this past cycle, representing a 44.5% increase since the last renewal. We remain
committed to supporting catalytic multidisciplinary research, bringing breakthroughs from laboratory bench to
patient bedside, while fostering a new generation of innovative, independent investigators.

Public health relevance
Overall Project Narrative The mission of the San Diego Center for AIDS Research (SD CFAR) is to drive HIV discoveries and foster cutting-edge research by San Diego investigators to improve the lives of people with HIV and to stop new infections, both locally and globally. The SD CFAR supports basic, clinical, behavioral and translational research programs across our member institutions and fosters the development of emerging investigators, including scientists new to HIV research.